ROLE OF ZINC IN SYNAPTIC TRANSMISSION IN THE HIPPOCAMPAL FORMATION

Several pieces of evidence suggest that endogenous opioids and zinc may interact to regulate neuronal excitability within the hippocampal formation. The purpose of this project is to conduct a systematic investigation into the effects of zinc on hippocampal neuronal excitability, with an emphasis on its interaction with enkephalin. The goal is to explain the nature of the effects of zinc and the mechanism(s) for its interaction with enkephalin. First it was necessary to determine the manner in which zinc levels were to be altered and the model for equating the significance of these changes to the functioning of the organism. As an initial approach we chose to attempt to alter zinc levels by systemic administration of zinc chloride or the intraviral zinc chelator, dithizone. The biological assay used was occurrence of wet dog shakes and seizures following subcutaneous administration of kainic acid (KA). We were unable to confirm the report of Porsche (IRCS Med. Sci. 11: 599, 1983) that subcutaneously administered Zn Cl2 prevents KA induced seizures in rats. Instead, we found no effect of Zn Cl2 in doses up to and including 100 mg/kg. This was true whether zinc was given before or after KA. In contrast, intraperitoneal injection of dithizone (12.5-100 mg/kg) has a profound and dose related effect on the effects of KA. When given 15 minutes after the subcutaneous injection of KA, it markedly potentiates KA activity. Dithizone also produces a transient decrease in hippocampal levels of enkephalin and dynorphin. It also produces transient increases in the hippocampal levels of a number of amino acids (viz., taurine, glutamate, glutamine, and GABA). It appears, then, that dithizone may prove to be a useful tool for exploring the actions of zinc on the hippocampus. Work in progress involves: (1) further characterization of the changes in peptide and amino acids induced by dithizone, and (2) examination of the electrophysiological effects of dithizone in the hippocampus.